Developing and credentialing murine models of ILC

This application is being submitted in response to the Notice of Special Interest (NOSI)
identified as NOT-CA-23-045 and under the parent award R01CA252378 and the Oncology
Models Forum.
Invasive lobular breast cancer (ILC) is the second most common special histological subtype of
breast cancer accounting for up to 40,000 cases yearly in the US, and if considered an
independent malignancy is the 6th most frequent cancer in women. Loss of E-cadherin (CDH1)
is the pathognomonic feature of ILC, being lost at the protein level in over 95% of cases. We
recently reported clinical outcomes in >30,000 cases of breast cancer showing that patients with
ILC suffer from late recurrences and worse outcome compared to the No Special Type (NST)
(1). Despite numerous studies showing unique clinical, histopathological, and molecular
features of ILC, clinical trials and guidelines mostly ignore the unique aspects of ILC and treat
NST and ILC as a single disease, a problem that has been recognized and voiced by the breast
cancer advocate community.
ILC is understudied compared to NST, in part due to the limited availability of models and to a
paucity of credentialing to identify those that faithfully represent the human disease. As such, it
is currently unclear which ILC models are most appropriate to test clinically meaningful
questions. Our team is at the forefront of ILC model development with generation and
characterization of ILC cell lines, patient-derived organoids (PDO) and patient derived
xenografts (PDX). We are committed to continued development, credentialing and sharing of
novel models of ILC. As part of the NCI Oncology Models Forum and NCI R01CACA252378 we
have developed and characterized ILC cell line models grown in 2D and numerous PDO. In this
supplement we will develop and credential novel mouse models of ER+ mammary cancer,
studying mice with clinically relevant ILC genetic drivers and transgenic expression of mutant
estrogen receptor. We will also develop and credential mouse-derived organoids for sue by
other researchers. In this way we aim to accelerate ILC research.

Public health relevance
Invasive lobular breast cancer (ILC), which is characterized by the near universal loss of E- cadherin and unique growth pa@ern, accounts for 10-15% of all breast cancer (up to 40,000 new cases per year) and is understudied in part due to a lack of credenGaled models in which to study the disease. Here we propose to develop and credenGal novel mouse models and mouse- derived organoids of ER+ ILC, thereby credenGaling them for future use in the study of ILC